Maintenance and Improvement of NINDS Infrastructure

NATIONAL INSTITUTES OF HEALTH NINDS Facilities Planning / Equipment
Bldg 35, GF352-4

The following laboratories and research support areas underwent renovations during FY 2022:

1. Perform renovation for the Chronic Fatigue Syndrome (CFS) space in Bldg 10. Location: NIH Bethesda Campus, Bldg 10
2. Perform renovation for NINDS Biospecimen Core Facility, Location: NIH Bethesda Campus, Bldg 8.
3. Perform renovation for Dr. Antonina Roll-Mecak , Cell Biology and Biophysics Section. Location: NIH Bethesda Campus, Bldg 35.
4. Perform renovation for Dr. Avi Nath/Dr. Bridgette Billioux, Division of Neuroimmunology & Neurovirology. Location: NIH Bethesda Campus, Bldg 10.
5. Perform a renovation for Dr. Daniel Reich, Dr. Steve Jacobson, Translational Neuroradiology Section/Viral Immunology Section. Location: NIH Bethesda Campus, Bldg. 10.
6. Perform renovation for Animal Facility, Bedding Removal system, Bedding Dispensing, Automated Bottle process system. Location: NIH Bethesda Campus, Bldg 35.
7. Perform a renovation for Dr. Sadhana Jackson, Dr. Desmond Brown and Dr. Prashant Chittiboina, Surgical Neurology Branch. Location: NIH Bethesda Campus, Bldg 10.
8. Perform additional back-up cooling system for NINDS Server Room. Location Bethesda Campus, Bldg 35.
9. Perform renovation for NINDS EM CRYO Laboratory. Location NIH Bethesda Campus, Bldg 35A.
10. Perform renovation for Electron Microscope/Light Imaging/ STEM Facility. Location: NIH Bethesda Campus, Bldg 37.
11. Perform renovation to replace the Porter phase1 RO System. Location: NIH Bethesda Campus, Bldg 35.
12. Perform renovation for the Deputy Stroke Branch Director. Location: NIH Bethesda Campus, Bldg 10.
13. Perform a renovation for NINDS Laboratory of Applied Developmental Biology, Location: NIH Bethesda Campus, Bldg 49.
14. Perform a renovation for Dr. Prashant Chittiboina, Neurosurgery Unit for Pituitary and Inheritable Diseases. Location: NIH Bethesda Campus, Bldg 10.
15. Perform a renovation for Dr. Sonja Scholz, Lasker Clinical Research Scholar, Neurodegenerative Diseases Research Unit, Neurogenetics Branch. Location: NIH Bethesda Campus, Bldg 35.
16. Perform modification to the existing Getinage Steam Sterilizer in the animal facility. Location: NIH Bethesda Campus, Bldg 35.
17. Perform a renovation for Dr. Mark Wagner, Tenure-Track Stadtman Investigator. Location: NIH Bethesda Campus, Bldg 49.
18. Perform a renovation and relocation for the Multi-IC Instrumentation Shop. Location: NIH Bethesda Campus, Bldg 13.
19. Perform renovation for Dr. Larry Latour, Stroke Branch, Stroke Diagnostics and Therapeutics Section (SDTS). Location: NIH Bethesda Campus, Bldg 10.
20. Perform a renovation on Siemens 17T MRI Scanner for MRI Research Facility. Location: Bethesda Campus. Bldg 10.
21. Complete renovation for the Protein/Peptide Sequencing Facility that supports multiple ICs. Location: NIH Bethesda Campus, Bldg 35.
22. Complete renovation for Dr. Rebecca Gottesman, Stroke Branch Director. Location: NIH Bethesda Campus, Bldg 10.
23. Complete a renovation for PET/CT Scanner Radiation Unit. Location: NIH Bethesda Campus, Bldg 49
24. Complete a renovation to install 12 AutoClave Machine in the Porter Building. Location NIH Bethesda Campus, Bldg 35.
25. Complete a renovation to replace a Rack Washer in the animal facility. Location: NIH Bethesda Campus, Bldg 35.
26. Complete a renovation for Dr. Meng Meng Fu, Statdman Investigator, Glial Cell Biology Unit. Location: NIH Bethesda Campus, Bldg 35A.
27. Complete a modification to NINDS Surgical Neurology Branch Conference Room Audio Visual. Location: NIH Bethesda Campus, Bldg 10.
28. Complete 35% design feasibility a design for BSL TC Room. Location NIH Bethesda Campus, Bldg 10.

The following pieces of major shared equipment were purchased to support many PIs:

1. One (1) new BioSafety Cabinets for Dr. Sonja Scholz (Neurodegenerative Diseases Research Unit). Location: NIH Bethesda Campus, Bldg 35.
2. Three (3) New BioSafety Cabinets for the Surgical Neurology Branch (SNB). Dr. Kareem Zaghloul & Dr. Prashant Chittiboina. Location: NIH Bethesda Campus, Bldg 10.
3. One (1) New BioSafety Cabinets for Dr. Sadhana Jackson (Developmental Therapeutics and Pharmacology Unit). Location: NIH Bethesda Campus, Bldg 10.
4. A New 10 gig switch for Dr. Mark Wagner Neocortex-cerebellum Circuitry Unit. Location: NIH Bethesda Campus, Bldg 49.
5. One (1) Nikon Optical Table for Dr. Meng Meng Fu (Glial Cell Biology Unit). Location: NIH Bethesda Campus, Bldg 35A.
6. One (1) TIRF Microscope for Dr. Meng Meng Fu (Glial Cell Biology Unit). Location: NIH Bethesda Campus, Bldg 35A.
7. One (1) Storage Locker for NINDS Information Technology. Location: NIH Bethesda Campus, Bldg 35.